Mapping and Modulating Brain States

Brain states are widely distributed patterns of neural activity, a consequence of specific physiological
conditions. Epidemiology demonstrates that early life adversity (ELA) followed by life-threatening fear
increases vulnerability to various mental and physical disorders, possibly by interfering with natural brain
states. Our understanding of natural brain states remains limited. Therefore, characterization of these brain
states, their changes after ELA and subsequent responses to threat, will be paramount to enabling precision
medicine targeting neuromodulatory systems to improve clinical outcomes. In order to define brain states
accurately under each condition and determine endogenous neuromodulation, measurements must be made
brain-wide, longitudinally, and with high spatial resolution.
In the F99 phase of this proposed research Taylor Uselman will continue developing statistical methods and
computational software to analyze images from his established longitudinal manganese-enhanced MRI
(MEMRI) protocol. In completed experiments, he acquired and processed MEMRI data with and without ELA
before and after exposure to acute threat. In new experiments, he is developing structural equation modeling to
test whether sample covariance between segments in MEMRI images is a meaningful measure of functional
brain architecture. He will then explore data-driven computational algorithms to characterize brain states and
underlying networks in all his longitudinal MEMRI datasets. He will also explore the influence of the
noradrenergic system on brain states, using viral transduction for chemogenetic activation of the locus
coeruleus followed by computational analyses of images acquired by his longitudinal MEMRI protocol. By
fulfilling this aim, Uselman will gain expertise in experimental design, neuroimaging, computational
neuroscience, and exogenous neuromodulation technologies.
In the K00 phase, Uselman will investigate control of pathological brain states via neuromodulation
technology. Based on his skills and results acquired in Aim 1, he will develop control theory algorithms toward
identification of targets for exogenous modulation of brain states occurring in pathological conditions. He will
then develop neuromodulation technology to influence identified targets for therapeutic intervention and assess
intervention efficacy by imaging.
The proposed work will yield innovative strategies to enable the identification and characterization of brain
states after ELA, sophisticated open-access software, and a generalizable imaging protocol. Ultimately,
application of these advanced methods to ELA’s effect on brain states will provide a deeper understanding of
increased vulnerabilities after ELA to mental disorders. An additional outcome of this fellowship will be the
preparation of a talented young investigator for a future productive career in brain science.

Public health relevance
Project Narrative Brain states are widely distributed patterns of neural activity of specific physiological conditions and regulated by neuromodulatory tone. This proposal will develop a democratized longitudinal imaging protocol to acquire detailed information about brain states with and without adverse childhood experiences, before and after threat experience. Sophisticated computational strategies will be applied for development of neuromodulatory technology aimed at ameliorating residual effects on brain states in adults.